Impacts of Adaptive Coronavirus Evolution on Viral Membrane Fusion

PROJECT SUMMARY
The continuous adaptation of SARS-CoV-2 generates variants of concern (VOC). New VOCs arise
independently and outcompete previous ones, consistent with ever increasing viral fitness. Most VOC
adaptations reside in the spikes (S), the complex multidomain glycoprotein trimers that bind viruses to cells
and mediate virus-cell membrane fusion. Well-characterized adaptations in the S receptor binding domains
(RBDs) alter RBD structural dynamics, receptor affinities, and antibody interactions. However, adaptations in
other S domains remain largely under-evaluated. This includes the S2 domains that execute virus-cell
membrane fusion. This proposal aims to elucidate consequences of VOC adaptive changes in the S2 domains.
The current VOC, omicron (o), has accumulated over six S2 mutations. Our central objective is to evaluate the
ways these and other S2 adaptations alter S protein dynamics to facilitate human cell entry. We will utilize a
collection of viral membrane fusion and cell entry assay systems to determine whether S2 changes reset the
dynamics of transient S protein intermediate states. These transitory states include RBD elevations that control
receptor binding and S2 refoldings from prefusion to fusion intermediate and through to postfusion
configurations. Our assay systems will employ fusion-competent virus-like particles (VLPs) for sensitive
evaluation of entry steps, soluble receptors as probes for RBD exposures, HR2 peptides for detection of
specific S transitional intermediates, replication-competent VSVSARS-CoV-2-S for selecting HR2 peptide-resistant
variants, and SARS-CoV-2 replicons and recombinant SARS-CoV-2 viruses for convincingly assigning specific
S2 amino acid substitutions to consequential redirection of virus-cell entry pathways.
Our preliminary results suggest that omicron S2 adaptations operate allosterically to alter S-receptor
interactions. The first aim will determine how S2 fusion domains control RBDs and their interactions
with receptors. We will identify specific VOC S2 mutations that control receptor reactivity and S stability. We
will determine how these mutations change viral entry requirements. Our initial results also suggest that
omicron S2 mutations change the pace of the conformational transitions facilitating membrane fusion. The
second aim will determine how S2 mutations control dynamics of fusion domains. We will determine
whether the rates of S2 structural transitions vary between VOCs. We will also select and characterize variants
resistant to inhibitors of the S2 structural dynamics and will find out whether these resistant variants have
unique requirements for the receptors and proteases that determine cell susceptibility to infection.
The results of this study will clarify currently obscure selective forces driving the human adaptation of past (α,
β, γ, δ), current (ο), and future VOCs. We expect the results will illuminate properties of the membrane fusion –
inducing S2 domains in ways that reveal new targets for inhibition of CoV entry.

Public health relevance
PROJECT NARRATIVE Adaptation of coronaviruses to human transmission and virulence present continuous threat to global health. SARS-CoV-2 and all other coronaviruses adapt primarily through variations in the conformationally dynamic and very large multidomain S glycoproteins that mediate virus-cell entry. As S protein complexity leaves the biological impacts of many such adaptative variations enigmatic, we propose to use diverse virus entry assays to elucidate mechanisms by which changes in the membrane fusion – inducing domains reset viral dynamics and cell entry properties in ways that may increase transmission or virulence.